Rescuing SYNGAP1 haploinsufficiency by redirecting alternative splicing

PROJECT SUMMARY
Synaptic transmission and plasticity are fundamental to neuronal functions, and dysregulations of synaptic
protein expression are direct causes of neurodevelopmental disorders such as autism. Over one hundred de
novo loss-of-function mutations in SYNGAP1 have been unambiguously associated with autism spectral
disorders and intellectual disability. Recent success in splice-switching oligonucleotides (SSOs) suggests that
redirecting splicing through genetic and SSO-mediated ablations is a promising approach to rescue
haploinsufficiency. We have identified an alternative splicing event in SYNGAP1 that leads to nonsense-
mediated mRNA decay (NMD) during mouse and human development. To determine whether the SYNGAP1
NMD exon is a viable therapeutic target, we investigate the regulatory mechanism and its functions using genetic
approaches, and determine whether genetic deletion and SSO suppression of the SYNGAP1 NMD exon can
rescue heterozygous knockout phenotypes in mouse mutants and patient-iPSC-derived neurons. Upon
completion, this project will provide genetic insights into the physiological functions of this SYNGAP1 NMD exon
and generate critical preclinical reagents to restore SYNGAP1 protein expression from haploinsufficiency.

Public health relevance
NARRATIVE Over one hundred de novo loss-of-function mutations in SYNGAP1 have been unambiguously associated with autism and intellectual disability. We uncovered a conserved SYNGAP1 alternative splicing event that is coupled with nonsense-mediated mRNA decay (AS-NMD) during normal mouse and human brain development. This research project aims to determine whether it is feasible to rescue SYNGAP1 haploinsufficiency by suppressing AS-NMD using genetically engineered mice and splice-switching oligonucleotides.